Understanding the molecular mechanisms that contribute to neuropsychiatric symptoms in Alzheimer Disease

GENERAL PROJECT DESCRIPTION: ABSTRACT
Neuropsychiatric symptoms (NPS) are core features of Alzheimer’s disease (AD) and related dementias
that are associated with major adverse effects on daily function and quality of life, and accelerate time to
institutionalization. Of all the NPS, depression is the most frequently observed symptom in people with mild
cognitive impairment and early AD. As the disease progresses, agitation, delusions and hallucinations become
more common, whereas apathy is the most persistent and frequent NPS throughout all the stages of AD. AD-
NPS share some clinical features with serious mental illnesses (SMIs), such as schizophrenia, bipolar disorder
and major depressive disorder, but whether these conditions share similar aethiopathies is unclear. Given that
reliable treatments for NPS in the context of AD and other dementias do not exist, a better understanding of the
molecular mechanisms and pathways underlying NPS in AD and other neuropsychiatric illnesses is a critical
next step to identify reliable biomarkers that could lead to novel therapeutics.
There are two overarching goals of this proposal. First, we will identify the molecular mechanisms and
neuropathological changes that are associated with the presence of NPS in patients with AD. Second, we will
examine if the mechanisms of pathology associated with NPS are shared or distinct among AD and SMIs. More
specifically, we propose to build multi-scale integrative models using phenomics and genomics data from 1,264
autopsy cases derived from a single brain bank. The bank includes detailed phenomics data such as well
characterized NPS, clinical diagnosis (AD and other neurodegenerative or neuropsychiatric traits), severity of
cognitive decline and neuropathology for each patient sample. From each case, we will apply innovative
approaches that reduce the cost and technical biases associated with conventional methods, and capture gene
expression signatures and epigenetic regulatory elements at the single-cell level. Novel deep-learning methods
will be applied for the multi-scale integration of neuropathologic changes with genetic markers and functional
genomic changes (such as changes in gene expression and enhancer sequences) within specific cell types, to
predict various NPS in AD and other neuropsychiatric traits; we refer to these integrative models as genotype-
marker-phenotype models. We expect that these models will enable us to assign genotypes and molecular
markers to specific NPS within AD and other neuropsychiatric traits at the single-cell level, an unprecedented
level of resolution. In addition, we will test the translational potential of the genotype-marker-phenotype models
to predict AD-NPS using independent large-scale biobank datasets, in which genotypes and electronic health
records are available. Successful completion of the proposed studies will have immediate utility by generating
potential biomarkers for NPS diagnosis and prognosis and by providing predictive models for patient stratification
in clinical trials. In the longer term, our models will help us create a blueprint for therapeutic strategies and
interventions to treat NPS in AD.

Public health relevance
PUBLIC HEALTH STATEMENT Neuropsychiatric symptoms (NPS) are core features of Alzheimer’s disease (AD) and related dementias, that contributes to early institutionalization and causes substantial caregiving and caregiver burden. Despite decades of research, reliable treatments for NPS in the context of AD and other dementias have not been found. The proposed studies will generate and integrate high-dimensional phenomics and genomics data in human brain tissue, that will inform us about the molecular mechanisms and pathways underlying NPS in the context of AD and other neuropsychiatric illnesses.